Decoding glioma evolution and progression by multi-dimensional single-cell profiling

PROJECT SUMMARY / ABSTRACT
Research Plan: Tumor evolution is a fundamental obstacle to cancer treatment, as malignant cells adapt to
treatment and change during progression. Understanding these adaptations is key to not only identifying
vulnerable gene targets, but also intervening during the optimal time window, before the targets become
obsolete. Charting this evolution requires understanding the genetic and epigenetic events that drive or
accompany disease progression, but these are largely unmapped in many malignancies. A case in point is diffuse
glioma, an incurable brain cancer composed of distinct cellular states that dramatically change in relative
abundance during glioma progression, ultimately changing the response to treatment. Efforts to decode glioma
evolution have been limited: while we have characterized the distinct glioma cell states, we have not found their
genetic and epigenetic drivers or measured how these affect cell states abundance throughout progression. To
this end, we have developed novel single-cell technologies to concurrently profile in the same cell i) the
transcriptome and epigenome (specifically, DNA methylation) and ii) the transcriptome and genome (DNA
mutations) at an unprecedented detection rate.
First, by combining genotype with cellular state data, I will define how somatic mutations dysregulate
transcriptional patterns, resulting in cellular states (Aim 1a), and characterize how somatic mutations dictate
glioma lineage structure (Aim 1b). By combining this with my postdoctoral work – characterizing how epigenetic
diversification contributes to transcriptomic diversity – I will create the first multi-dimensional model of glioma
evolution. Second, I will use our method to measure single-cell DNA methylation and transcriptional profiles in
samples taken longitudinally from the same patients. This will test the hypothesis that dysregulated epigenetic
patterns contribute to glioma progression, and it will not only provide a multi-dimensional model of glioma
progression, but will also provide epigenetic markers to track progression in the clinic (Aim 2). Finally, I will
improve diagnosis in the clinical setting by designing a tool that infers cell state composition, progression and
likely response to treatment based on data from the bulk DNA methylation assay that is routinely done in the
clinic (Aim 3). These studies will pave the way towards novel glioma treatments, accurate diagnoses and optimal
timing of treatment.
Career Development Plan: I have outlined a 5-year career development plan to meet my goal of becoming an
independent investigator in cancer biology who focuses on intrinsic determinants of tumor progression and
response to treatment. I have assembled a Mentorship Committee of leaders in the field, with whom I will train
to close remaining knowledge gaps in multi-omics evolution and how to leverage my results to support clinical
care. Finally, the Broad Institute constitutes the ideal environment for attaining my scientific and career goals,
given their outstanding research communities and track records of training independent scientists.

Public health relevance
PROJECT NARRATIVE Diffuse glioma evolves via the interplay of mutations, DNA methylation changes, and altered gene expression, often resulting in a more aggressive and treatment-resistant form of the disease. This research proposal seeks to dissect the mechanism of glioma evolution and progression through stages of severity. Understanding the mechanism of glioma evolution can both provide targets to halt it, thereby paving the way for improved therapies and treatment timing.